Molecular Prosthetics and Lego Chemistry

ProjSeucmtmary
Humadniseacsaeussbeyddeficioefpnrcoitfeeusinncctoilolnecrteipvreealsmyeanjtuonrmemtedical
neeWde.artehupsioneetrhidenegvelopomfMeonltecPurloasrthsemtaimlcolsl,ecutlhaemtsimitche
functoifmoinssspirnogteWiehnysp.othtehstaihtzreeobunsatuorfleivsiynsgtweimplselrmiimtperfsemcatll
molecmuilmeitcobsesufficfiorerensttoroafpthiyosnioilnmoagncyyaseOsu.prrelimsitnuadorifnyeastural
produtchtpasetrfporromteifnu-nlcitikinyeoenasasnthdumaenpitaherhleiigaehnlcyouraTghiensget.udies
furtlhitenhrktioslerfaoinrmcpeerfetcomtoiloencbuiloasnryisctienmwshitchhsemamlolleccuollelsabora
witchompensnaettowroyorfpkrsoteBiunisl.odnitnhgsitsrofnogundaotfpiroenlimriensauwrleytpsl,atno
extenspirvoeablneoydptitmhicezaepafcoisrtmyamlollectuoalceatssprosthoentshemesolecsuclaaalrned
therterbeycaytsftibcrmoiscirso,acnyetmiiacan,dasthmTah.ipsrojweicfltulrtlhaetyrhfeoundaftoiron
applytihsniagsmaepprotaomcahnoythceurrreinntcluyrhaubmladeniseacsaeussbeymdisspirnogteins.
Natuprraolduscetrasvsexceptsitoanrpatoliinfngottrshdeeveloopfmtehneatsnemdanoythteyrpes
ofhumatnherapebustyinctsh,oeftshiescsoempmleoxlecaunltdehsedierrivaotftiervneepsreasmeanjtosr
bottleWneewcitklh.lupsursiunpearamlolregelenearnaadlutomastyendthaectcietcsossucchompounds
Ovetrhpeasdtecawdeehavdeevelaonpiendcreagseinnegsrlmayalmlollecsuylnethpelsaitsbfaosreomdn
thieterastsievmeobfbliyfuncMtIiDobAnoarlonbautielbdlioncgTkhsip.slatfiosnromwextensuisveedly
worldawnidedneabulsetdodeveleosptsoxdiecrivaotftihvceelsinivciatblaullhty,ightloyxainct,ifung
amphoteBrtihcaitrnneowbeiandgvantcoewdacrldintirciaWalelasl.sroececnrtelayatmeadchitnheat
automattheitssypoefsyntheBsuisl.doinanlgolfthimsomentwuemn,owplatnolaunTchheNatural
ProductPoromjeetcatrgegteinnegarnadalutomastyendthaectcietcsomsosntatuprraolduScytnse.rgizi
witchomplemeenfftoarbrtymysanoythreerseagrrcohuwposrldwiewdiedl,eltertmhimenienimnuummber
ofbuilbdlioncfgkrsowmhimcohsntatuprraolduccatbnsemadep,ursnueewmethotdomsakaenidterativ
couptlheebsueilbdlionctgkosgetahneddre,vegleonperabliiozmeidsmtertaitcteotgriaenssbfuoirlmbdlioncgk­
derilviendeparrecurisnotcroosmplpeoxlycnyactluiprcraolducftr-almiekweoSrikmsit.loTahreHuman
GenomPerojTehcNeta,tuPrroadluctPormoejweiscletlrtvorealtlhgyelosbcailenctoimfmiucntioctoyllectiv
achiaemvaejaodrvanwciethpeotenttotiraalnssfcoiremanncmdeedicine.

Public health relevance
Project Narrative This program targets molecular scale prosthetics to replace missing proteins that underlie a range of currently incurable human diseases and a general and automated platform for making these and many other types of natural product-based therapeutics. Collectively, these efforts stand to unleash the substantial untapped potential for naturally occurring small molecules to better human health.